Evolution, Optimization, and Application of Genome Editing Technologies

Project Summary/Abstract
Gene editing technologies enable the efficient targeted introduction of desired genetic alterations of interest in
a wide range of organisms and have broad applications for biological research and human therapeutics. First-
generation gene editing platforms use site-specific endonucleases (e.g., RNA-guided CRISPR-Cas nucleases)
to induce targeted DNA double-stranded breaks, using cellular DNA repair mechanisms to create mutations.
More recently developed gene editing platforms include the CRISPR cytosine or adenine base editors, which
use Cas9-directed single-stranded DNA deaminases to induce targeted C-to-T or A-to-G alterations,
respectively, and CRISPR-guided prime editors (which use a reverse transcriptase-dependent process that
can induce any nucleotide substitution or small indel mutations). Although gene editing technology
development has accelerated over the past decade, many important limitations of existing platforms have yet
to be addressed and opportunities remain to create multiple new impactful technologies enabled by recent
advances. For the next cycle of this MIRA, the focus will be on four broadly important Challenges: 1) expand
the sensitivities and scope of gene editor off-target detection technologies; 2) engineer next-generation prime
editors with enhanced and optimized architectures; 3) create new epigenetic editing platforms for targeted
heritable activation of human genes; and 4) develop new universal modalities for delivery of all gene editors to
human cells.

Public health relevance
Project Narrative The experiments of this proposal seek to improve technologies that enable efficient targeted alterations of gene sequence or change the amount of gene products synthesized in human cells and other organisms. Successfully accomplishing the goals of this application will broaden the utility of these technologies for a wide range of biomedical research applications and for developing potential therapeutics for multiple human diseases.